Alzheimer's tauopathy phenotype and the microRNA22-3p: implication for pathogenesis

PROJECT SUMMARY
One common pathologic hallmark of Alzheimer's disease (AD) and related tauopathies is the abundant
presence of abnormal aggregates of highly phosphorylated tau protein in the brain parenchyma. Because the
etiology of the vast majority of these cases (late-onset) is not known, currently there are no effective
preventative measures or therapeutic approaches against them. Considering the increasing number of
individuals affected by these disorders there is a sense of urgency to identify the mechanisms responsible for
the onset and development of their neuroptahologic phenotype.
Recently, small non-coding RNAs, also called microRNAs (miRNAs), have emerged as important post-
transcriptional master regulators of several key cellular processes involved in neurodegeneration.
Consistent data in the literature showed that miRNAs are dysregulated in AD and related tauopathies.
However, since these studies typically assessed a single time point in the disease evolution they did not
address whether the changes antecede or follow the onset of the pathology. Using an unbiased approach, in
our preliminary studies we discovered an age-dependent increase in the expression levels of a specific
miRNA, miRNA22-3p, in the hippocampus of a relevant mouse model of tauopathy at an early stage of its
phenotype. Importantly, we confirmed this observation also in post-mortem human tauopathy brain tissues
when compared with age-matched healthy controls. Additional studies revealed that this miRNA directly
modulates pathologic tau accumulation. The hierarchical hypothesis of this research program is that miRNA22-
3p directly contributes to the tauopathy pathogenesis through regulation of specific targets involved in tau
metabolic pathways, and that the modulation of its level represents a new therapeutic approach for the
treatment of these diseases.
To test our hypothesis, we will over-express miRNA22-3p in a relevant tauopathy mouse model (Specific Aim
1) and down-regulate miRNA22-3p expression levels in the same model (Specific Aim 2). In order to establish
its cellular source and contribution to the tau phenotype, we will generate tauopathy mouse models with cell-
specific miRNA22-3p deficiency (Specific Aim 3). In all these models we will assess the effects and
mechanisms of manipulating this specific miRNA level on tau neuropathologic phenotype and cognitive
functions.
Overall the long-term goal of our research proposal is to establish the functional role that miRNA22-3p plays in
the pathophysiology of AD and related tauopathies, and ultimately by identifying its biological targets to
develop novel and viable therapeutic tools and strategies against these devastating diseases.

Public health relevance
NARRATIVE Alzheimer's disease (AD) and tauopathies are the most common types of dementia in the elderly. Clinically they are characterized by memory loss and impairment of cognitive functions secondary to a progressive accumulation in the brain of toxic tau protein. Currently, because the mechanisms responsible for this accumulation remain unknown, no therapy is available against these devastating diseases. In recent years, small molecules called microRNAs have emerged as master regulators of brain health and disease. Although their levels are altered in AD and tauopathies, we still do not know whether they are responsible for them. Our research program will test the hypothesis that specific microRNAs participate directly to the onset of these diseases, and for this reason they represent a target that we can use to develop novel therapies against them.